Optimizing the use of ketamine to reduce chronic postsurgical pain

Chronic pain contributes significantly to the current opioid epidemic. Up to 20% of postoperative patients
develop chronic postsurgical pain (CPSP). CPSP is highly associated with chronic opioid use and dependence,
and yet routine multimodal analgesia as a combination of acetaminophen, NSAIDs, and anti-neuropathic
agents is only moderately effective in preventing CPSP. The incidence for CPSP is particularly high in patients
undergoing mastectomy or breast conserving surgery with lymph node dissections (25-60%). This specific
postsurgical pain condition is known as post-mastectomy pain syndrome (PMPS), and a recent study showed
that 1 in 10 patients continue to use opioids 3 months after surgery. We aim to study the effectiveness of
perioperative ketamine for the prevention of PMPS, within the NIH HEAL Pain Management Effectiveness
Research Network (Pain ERN). Our rationale is that ketamine can reduce key risks for CPSP including acute
pain severity, anxiety and depression, and pain catastrophizing, and in doing so can prevent the development
of PMPS. Mechanistically, ketamine is known to enhance endogenous cortical control of pain and mood. There
is strong clinical evidence for perioperative ketamine infusion in reducing postsurgical pain, and for a single
ketamine bolus (0.3-0.5mg/kg) to treat depression and anxiety associated with postsurgical pain. However,
studies are urgently needed to test the efficacy of ketamine in the perioperative period for preventing CPSP,
particularly PMPS, in a large cohort of patients and to assess clinical variables predictive for chronic pain
severity and for treatment effects. We aim to conduct a multi-site, three-arm RCT to study the effectiveness of
ketamine in reducing the incidence and severity of PMPS. 750 patients after mastectomy or breast conserving
surgery with lymph node dissection will be randomized to receive either a standard continuous ketamine
infusion starting after induction (bolus of 0.35mg/kg followed by infusion at the rate of 0.25mg/kg/hr) and
continued for 3 hours after surgery, a regimen of single-bolus ketamine (0.6mg/kg) administered right after
surgery, or placebo (saline) control. To maintain the pragmatic nature of an effectiveness trial, all patients will
receive routine postoperative multimodal analgesia. Compatible with recent NIH recommendations, we will
assess pain, function and mood over 12 months after surgery. We will use Brief Pain Inventory (BPI) severity
score at 3 months after surgery as primary endpoints. Secondary endpoints include pain incidence, BPI, short-
form McGill's Pain Questionnaire, opioid use, NIH PROMIS scales, Hospital Anxiety and Depression Scale,
Pain Catastrophizing Scale, and Breast Cancer Pain Questionnaire. We will also build precision medicine
models to analyze clinical variables associated with CPSP and with success of ketamine treatment.
Agreements have been reached with 11 sites, including 7 Clinical and Translational Science Awards (CTSA)
hubs, NYU, Columbia, Einstein, BWH, Washington University at St. Louis, Duke, and Univ. Washington, to
carry out this study successfully.

Public health relevance
PROJECT NARRATIVE Approximately 20% of patients who undergo surgery develop chronic pain, and while chronic postsurgical pain (CPSP) is highly associated with impaired functional recovery and persistent opioid use and dependence, current standard postoperative multimodal analgesia is only moderately effective for its prevention. In a three- arm randomized controlled trial, we aim to study the effectiveness of adding perioperative continuous or single- bolus ketamine to routine postoperative care, for the prevention of post-mastectomy pain syndrome (PMPS), one of the most common CPSP conditions. Ketamine is a low risk treatment option that is easy to implement in a wide range of clinical settings, and thus our proposal can substantially impact postoperative pain management, and in doing so can contribute significantly to our combat against the opioid epidemic.